in situ Epigenetic Profiling of Single Cells in Kidney - Kim Diversity Supplement 2023

Project Summary/Abstract
We have recently developed a microscopy-based method that, for the first time, enables interrogation of histone
modifications at single loci in single cells. This method is termed SCEPTRE (for Single-Cell Evaluation of Post
TRanslational Epigenetic encoding) and utilizes super-resolution imaging to directly resolve and quantify histone
modifications at specific DNA or gene loci that are labeled by immunofluorescence and DNA fluorescence in situ
hybridization (FISH), respectively. We propose to develop SCEPTRE, a method currently in use with cultured or
isolated cells, for epigenetic profiling of kidney tissues and to use SCEPTRE to study healthy aging and
senescence in mouse kidney tissues.

Public health relevance
Project Narrative The kidney is a complex organ whose essential roles include filtering waste from the blood, regulating blood pressure, and maintaining electrolyte balance. This project will develop a microscopy-based technique to study the organization of the genome of kidney cells and it will use the new technique to study aging in model mouse kidney tissue. The tools and findings of this project will enable researchers to study genome organization in kidney or other tissues and will illuminate the molecular details of aging.